Ecological Momentary Assessment of Racial/Ethnic Microaggressions and Cannabis Use among Black Adults

Project Summary/Abstract
Despite being one of the largest racial minority groups in the United States (U.S.), Black individuals experience
striking health disparities, particularly in terms of cannabis-related outcomes. One possible reason for this is
that this Black individuals in the U.S. are disproportionately affected by stressful life conditions, including race-
based discrimination, which may lead to higher rates of cannabis use and use-related problems. Racial/ethnic
microaggressions (MA) are more commonly experienced than overt discrimination (e.g., hate crimes) among
Black individuals, yet almost no research has examined their role in cannabis use, including whether
experiencing MAs is temporally proximally related to cannabis use motivation and cannabis use and related
problems and whether MAs account for significant and unique variance in these cannabis outcomes. The goal
of this R21 project, which is in direct response to PA-20-195, is to elucidate the role of MAs in cannabis use
and cannabis use motivation among Black adults using time sampling methodology (over the course of 21
days). Participants (N=100; 50% female) will be Black adults who endorse regular cannabis use. Further, the
present proposal will determine whether negative affect (anxiety, depression, anger) in response to MA
accounts for the relation between MAs and cannabis use motivations (i.e., greater craving, intention to use,
and coping-oriented motives for cannabis use) and use (i.e., greater frequency of cannabis use, and more
negative use-related consequences), and test theoretically driven culturally relevant resilience factors,
including religiosity, ethnic-racial identity, and positive coping with racial discrimination. This proposal can
significantly advance our knowledge of precursors to risky cannabis use and related problems within the Black
community and provide critical insight for future prevention and intervention programs. The proposed research
project supports the National Institute of Drug Abuse’s strategic plan’s Goal 1: “identify the biological,
environmental, behavioral, and social causes and consequences of drug use and addiction across the
lifespan.” It is also in line with NIH’s UNITE initiative’s aim to support “new research on health disparities,
minority health, and health equity”.

Public health relevance
Project Narrative Cannabis misuse among Black individuals in the United States poses a major public health concern. The proposed research uses ecological momentary assessment to strive to better understand antecedents of cannabis use motivation and cannabis use and related problems among this population by examining racial/ethnic microaggressions (MAs) – brief, subtle, yet common forms of everyday discrimination due to racial/ethnic status – that may prompt Black individuals to be more motivated to use cannabis to mitigate MA- related negative affect and engage in risky patterns of cannabis use. Through this research, we also will explore mediational processes and moderators in the link between MA and cannabis use and related problems that will inform future intervention and prevention efforts for this neglected health disparities group.